Neurodevelopmental role of a tRNA methyltransferase underlying intellectual disability

PROJECT SUMMARY
Gene regulation at multiple levels is critical for nervous system development and function. A number of
mutations leading to global dysregulation of gene expression have been found to disproportionately affect the
nervous system, leading to neurodevelopmental and neurodegenerative disorders. Transfer RNAs (tRNAs),
which recognize codons and add the appropriate amino acid to growing polypeptides, can dynamically regulate
translation. tRNAs are heavily post-transcriptionally modified to regulate their structure, stability, and fidelity.
ALKBH8 is one of two metazoan homologs of the yeast tRNA methyltransferase TRM9. Stop and missense
mutations in human ALKBH8 have recently been shown to cause intellectual disability in four families.
However, ALKBH8’s role in the nervous system remains unknown. To address this, I have generated null
alleles in Drosophila and found that ALKBH8 regulates synapse formation. My preliminary data suggest
ALKBH8 attenuates synaptic growth by limiting oxidative stress through the methylation of tRNA-
selenocysteine, which yields the rare 21st amino acid selenocysteine for the synthesis of selenoproteins. In AIM
1, I will employ genetic, pharmacological, imaging, and bioinformatic approaches in Drosophila to define the
links between ALKBH8, selenoproteins, and synaptic growth and investigate the impact of a human ALKBH8
mutation in the nervous system. In AIM 2, I will build on the skills gained during my dissertation work by
expanding into human-derived pluripotent stem cells (iPSCs) to model neurological disorders and probe
potential treatment strategies.
The proposed experimental plan will provide mechanistic insight into how tRNA modifications regulate gene
expression during nervous system development. The proposed training plan will provide me with the technical,
academic, and professional skillset to thrive for the remainder of my predoctoral training and beyond as I
transition into a postdoctoral position. Successful completion of the F99/K00 aims will place me in a unique
position to investigate mechanisms underlying neurodevelopment disorders in two model systems with
complementary strengths and identify potential therapeutic treatments for affected individuals.

Public health relevance
PROJECT NARRATIVE tRNA modifying enzymes are emerging as important regulators of nervous system development and function due to their links to neurodevelopmental and degenerative disorders, yet their roles in the nervous system remain largely elusive. The studies proposed in the F99 phase will elucidate the role of tRNA methyltransferase ALKBH8 in neurodevelopment and explore potential strategies to ameliorate adverse effects. The translational training proposed for the K00 phase and professional development plan will build on this foundation to enable me to establish a lab with the expertise to uncover the cellular and molecular mechanisms underlying neurodevelopmental disorders and identify candidate therapies.